Macrophage Expression Quantitative Trait Loci and Tuberculosis Pathogenesis

Despite continuous efforts to eradicate tuberculosis (TB), Mycobacterium tuberculosis (Mtb) is still the leading
infectious agent worldwide. Most people heavily exposed to Mtb become infected and develop latent Mtb
infection (LTBI). Importantly, Dr. Hong’s collaborators identified ~7% of individuals who are heavily and
repeatedly exposed to Mtb resist developing LTBI (resister or “RSTR”) in a household contact (HHC) study in
Uganda. However, clinical and epidemiological studies were not able to differentiate these clinical phenotypes
(RSTR vs. LTBI). To discover genetic determinants of this resistance phenotype, Dr. Hong mapped expression
quantitative trait loci (eQTLs) associated with gene expression in Mtb-infected, but not uninfected monocytes
from the same patient cohort. This genetic approach revealed that 29 eQTLs were significantly associated with
the expression of 16 genes in response to Mtb infection. Despite the discovery of Mtb-specific genetic
signatures, the functional importance of these eQTLs and their target genes in macrophage responses to Mtb
infection deserves to be further investigated. In the current proposal, the primary goal is to discover the global
human genetic regulators (genes and variants) of Mtb-induced macrophage antimicrobial pathways. Dr. Hong
hypothesizes that Mtb-dependent eQTL monocyte response genes (termed “Mtb eQTL gene”) and variants are
global regulators of macrophage responses to Mtb and mediate critical proinflammatory and antimicrobial
responses. Alternatively, these genes may be hijacked by Mtb to favor its survival. In Aim 1, she will determine
the mechanisms of how Mtb eQTL genes regulate macrophage antimicrobial responses to Mtb and other
pathogens. In Aim 2, she will determine the allele-specific antimicrobial macrophage mechanisms of Mtb
eQTLs and their association with clinical outcomes. Significant findings from this project will enrich our
understanding of how Mtb eQTL genes and variants modulate macrophage responses to Mtb, directing
towards understanding why individuals have different susceptibility to Mtb infection and TB disease as well as
whether these insights can lead to novel treatment or diagnostic strategies.
Dr. Hong, Assistant Professor at the University of Pennsylvania School of Nursing (primary) and the Perelman
School of Medicine (secondary), is a clinician scientist with a Ph.D. in TB research and epidemiology. Dr. Hong
is seeking a K08 Mentored Clinical Scientist Research Career Development Award to acquire advanced
training and mentorship for further studying the influence of genetic determinants on resistance and
susceptibility to Mtb infection and TB disease. Since her research focus has shifted from clinical epidemiology
to immunogenetics in TB, this K08 training award will provide her with the necessary protected time to fill the
gaps in her research skills. By implementing the studies described in this proposal under the guidance of
expert mentors, Dr. Hong will be well-positioned as an independent investigator, characterizing novel
mechanisms of TB susceptibility with expertise in TB immunogenetics.

Public health relevance
PROJECT NARRATIVE Although several lines of evidence suggest that genetic variation influences susceptibility to Mycobacterium tuberculosis (Mtb) infection or tuberculosis (TB) disease, our understanding of the specific genes and variants associated with TB susceptibility remains incomplete. This proposal aims to investigate the roles and mechanisms of global human genetic regulators in Mtb-induced macrophage antimicrobial pathways. By combining an epidemiological approach with the study of underlying immunogenetic mechanisms, we aim to uncover potential targets for host-directed therapies and establish a means of TB risk screening.